Fetal alcohol exposure: effects on immunity of the premature newborn

Alcohol use during pregnancy continues to be a significant issue but its contribution to adverse outcomes in the
premature newborn remains understudied. We previously reported that approximately one in three very low
birthweight (VLBW) premature newborns were exposed to alcohol in utero per maternal report. This exposure
was linked to an increased odds of late onset sepsis (LOS) and bronchopulmonary dysplasia (BPD). In our
animal models of in utero alcohol (ETOH) exposure, alveolar macrophage (AM) immune responses against
bacteria were decreased in multiple species of newborn pups. These alterations included increased oxidant
stress and delayed AM maturation but were improved by treatment with the antioxidant glutathione (GSH). In
the newborn lung, the ontogeny of the mature AM remains controversial but fetal monocytes mature to AM via
PU.1 in response to Granulocyte/Macrophage Colony Stimulating Factor (GM-CSF). In utero alcohol exposure
decreases GM-CSF but its effects on circulating monocytes and different monocytic cell pools within the
developing lung are unknown. For the adaptive immune response, antigen presentation depends on the MHC
class II molecule human-leukocyte antigen DR (HLA-DR) and immune depression is characterized by
decreased HLA-DR expression on antigen-presenting cells such as monocytes or macrophages. Recently,
immune depressed states such as sepsis have been linked to increases in the check point inhibitor
programmed cell death protein (PD)-1 and its ligand PD-L1. In neonatal mouse monocytes and AM, we found
that in utero ETOH exposure increased immunodepression by increasing oxidant stress, diminishing zinc and
GM-CSF, decreasing MHC-II expression, and increasing PD-1/PD-L1. However, GSH or Zinc treatments
blocked these effects. In tracheal aspirates of intubated VLBW infants, HLA-DR was diminished in AM from
babies who developed LOS while PD-L1 was increased in babies who developed LOS or BPD. In addition, PD-
1 and PD-L1 expressions were increased in AM from VLBW infants with in utero alcohol exposure compared to
unexposed AM. Using established in utero ETOH mouse models plus translational studies of VLBW newborns,
our overall objectives are to: 1) define in utero ETOH effects on innate and adaptive immune defenses of
monocytes, monocyte-derived macrophages (MDM), and AM against bacterial challenges; 2) determine if
clinically relevant interventions to diminish oxidant stress (GSH, GM-CSF and Zinc) will improve innate and
adaptive responses; 3) validate ethanol metabolites Fatty Acid Ethyl Esters (FAEEs) and phosphatidylethanol
(PEth) as biomarkers of in utero alcohol exposure in VLBW newborns and 4) determine phenotype plus innate
and adaptive defenses of human monocyte, MDM, and AM samples from VLBW newborns with/without fetal
alcohol exposure. Improving identification of VLBW newborns with fetal alcohol exposure and
understanding its immunodepressive effects superimposed on immature immune defenses related to
prematurity have important implications for this vulnerable population and their risk of LOS and BPD.

Public health relevance
Project Narrative Maternal alcohol exposure is reported to occur in one in three premature newborns, increasing the risk of infection and lung disease in very low birth weight newborns. In this proposal, using a neonatal mouse model of in utero alcohol exposure combined with translational studies of very low birthweight newborns, we will determine whether in utero alcohol induces immunodepression and immune dysfunction in the premature newborn and whether these changes are modulated by clinically relevant modulators. These results will have important implications regarding the identification of alcohol exposure in premature newborns and the mechanisms underlying systemic and pulmonary immune complications in this high risk population.